Markers and regulation of regulatory CD8+ T cells during influenza-induced lung immunopathology

Project Summary/Abstract
Influenza (Flu) infection is a leading cause of respiratory disease and associated death in the world.
The annual flu epidemics are estimated to result in 3-5 million cases of severe illness and more than 250,000
deaths. A strong effector immunity is desired for viral clearance, it however can lead to immunopathology if not
properly controlled. Severe and fatal influenza diseases are accompanied by an aggressive pro-inflammatory
response and an insufficient anti-inflammatory immunity. The production of the immunoregulatory cytokine IL-
10 by flu-specific CD8+ T cells is critical in limiting the lung immunopathology during infection, contributing to
host survival and recovery. Knowing how to identify these regulatory CD8+ T cells and understanding how they
develop and function are essential for learning how to control flu-induced lung immunopathology. This makes
our work highly significant. While much is known about the CD4+ regulatory T cells, the molecular signature
and mechanisms that regulate the development and function of IL-10+ regulatory CD8+ T cells remain poorly
understood, particularly in the context of influenza-induced airway inflammation. We recently generated an IL-
10GFP/Foxp3RFP dual reporter mouse model that enables detection of IL-10 and Foxp3 in live cells, and
undertook a screening for the presence of IL-10+ and/or Foxp3+ T cells under normal and pulmonary
inflammatory conditions. We found that Foxp3- IL-10+ CD8+ T cells are present in various organs and disease
conditions, and are the major contributors to IL-10 production in the airway during influenza infection. These
Foxp3- IL-10+ CD8+ T cells exhibit profound immunoregulatory function against pro-inflammatory innate and
adaptive immune responses, indicative of a therapeutic potential. There are however no reliable markers for
Foxp3- IL-10+ CD8+ regulatory T cells. We hypothesize that molecular signatures and pathways associated
with the development and function of IL-10-producing regulatory CD8+ T cells can be exploited to
develop therapeutic strategies against influenza-induced lung immunopathology. Our preliminary
studies identified a novel surface signature LAG3hiCD25hiBTLAloCD226lo and the critical transcription
factor TCF1 in IL-10+ CD8+ T cells during influenza infection. We propose experiments in two Specific Aims to:
(1) determine and validate signature surface markers of IL-10-producing regulatory CD8+ T cells; and (2)
determine the role of TCF1 in IL-10-producing regulatory CD8+ T cell development and function. This work is
highly innovative as we utilize comprehensive biochemical, genetic and genomics approaches with unique
transgenic mouse models, and have exciting preliminary data that can be expanded to provide information of
surface markers and critical signaling pathways for a better understanding of the development and
immunoregulatory function of IL-10-producing CD8+ T cells during Influenza infection. We expect to unravel
potential molecular mechanisms through which flu-induced pathogenesis can be better controlled, which may
enhance our ability of developing strategies to control virus-induced immunopathology, morbidity and mortality.

Public health relevance
Project Narrative Influenza (flu) infection is a leading cause of respiratory disease and death worldwide, causing 3-5 million cases of severe illness and more than 250,000 deaths during an average flu season, in which severe influenza diseases are accompanied by an aggressive pro-inflammatory response and an insufficient anti- inflammatory immunity. The production of the immunosuppressive cytokine IL-10 by effector T cells is critical in limiting the immunopathology during flu infection, however, our understanding of how this immunomodulatory event is regulated is very limited. The proposed research will define the biomarkers of regulatory CD8+ T cells, as well as transcriptional mechanisms how these cells develop and function, which will generate key information to help facilitate our understanding and enhance ability of modulating immune regulation to limit immunopathology, morbidity and mortality during flu infection.